Role of hepatic IkBb-mediated sustained NFkB activation in neonatal lung injury and abnormal development

PROJECT SUMMARY Bronchopulmonary dysplasia (BPD) is the most common morbidity complicating preterm birth and predicts poor pulmonary and neurodevelopmental outcomes. Despite the well-documented association between inflammation and BPD, no safe and effective anti-inflammatory therapies to prevent BPD are currently available. How the neonatal innate immune response contributes to the pathogenesis of BPD is unknown, limiting therapeutic options. Our overarching aim is to determine the molecular mechanisms linking the neonatal innate immune response and impaired lung development that contributes to the pathogenesis of BPD. Importantly, recent studies in my laboratory identified a developmentally-regulated, hepatic-specific pattern of expression for key inhibitory proteins of the transcription factor NFκB. As NFκB plays a central role in regulating innate immunity, these findings have led us to propose a new organizing hypothesis linking the neonatal hepatic innate immune response to pulmonary injury. We hypothesize that the hepatic expression profile of the IκB family of NFκB inhibitory proteins results in a sustained pro-inflammatory innate immune response to systemic inflammatory stress that contributes to ongoing pulmonary inflammation, injury and impaired development. We propose three specific aims to test this hypothesis and determine the immunologic cross-talk between the developing lung and liver. In Aim 1, we will test whether the intracellular balance of IκB?/IκB? dictates the magnitude, duration and selectivity of the inflammatory-stress induced NFκB transcriptome. In Aim 2, we will test whether a robust and sustained pro-inflammatory neonatal innate immune response contributes to lung injury and abnormal development. In Aim 3, we will test whether inhibiting inflammatory stress-induced, IκBβ-mediated hepatic NFκB signaling prevents prolonged pro-inflammatory gene expression and attenuates neonatal lung injury. Our hypothesis represents a paradigm shift in how we approach the prevention of BPD by linking a sustained pro-inflammatory neonatal innate immune response mediated by hepatic IκBβ/NFκB signaling to lung injury and subsequent abnormal development. These studies will provide the foundation for translational work aimed at pharmacologically targeting IκBβ /NFκB signaling to prevent BPD in at-risk infants.

Public health relevance
PROJECT NARRATIVE Despite advances in neonatal care, the incidence of bronchopulmonary dysplasia (BPD) has remained unchanged over the past 30 years. BPD resulting from perinatal lung injury predicts lifelong impairment in pulmonary function as well as poor neurodevelopmental outcomes. How the neonatal innate immune response contributes to lung injury and the development of BPD is unknown. This project will determine the molecular mechanisms linking the innate immune response to neonatal lung injury, so that new strategies can be developed to prevent BPD in at-risk infants.